Technology Development for Biological Imaging with XFELs

Project Summary / Abstract
Determining the structure and conformational dynamics of large protein complexes as well as other
biological nanoparticles at room temperature with near atomic resolution has the potential to greatly impact
structural biology and our knowledge of biomolecular function and interactions. A major bottleneck in
structural biology is that while many critical cellular functions are performed by membrane proteins, they have
proven intractable to structure determination by traditional x-ray crystallography, in which x-ray radiation
damage is mitigated by spreading the radiation dose over many molecules in a crystal. Consequently, most
membrane protein structures remain unknown to date. While cryo-electron microscopy (cryo-EM) has been
successful in obtaining high-resolution structural information from large biomolecules and nanoparticles, it
requires freezing of the sample to mitigate electron-induced radiation damage and cryogenic measurement
makes it impossible to visualize fast conformational changes.
X-ray free electron lasers (XFELs), which produce ultra-short and ultra-bright x-ray pulses, allow us to
break this nexus between resolution and radiation damage by utilizing the “diffraction-before-destruction”
principle and promise imaging at unprecedented spatio-temporal resolution. Over the last decade since the
opening of the world's first XFEL, the Linac Coherent Light Source (LCLS) at SLAC National Accelerator
Laboratory, protein structure determination at room temperature to near-atomic resolution by serial-
femtosecond nanocrystallography (SFX) has been demonstrated. However, several challenges and limitations
remain that need to be addressed to fully utilize the capabilities of these new light sources and the upcoming
next generation XFELs for structural biology.
The overall objective of this proposal is to enable new science by addressing several of the current
technological and methodological challenges in x-ray diffractive imaging of biological samples with XFELs, in
particular in the areas of sample preparation for membrane proteins that, generally, suffer from low abundance
and/or are hard to crystallize, sample introduction technologies enabling high data acquisition rates, and novel
approaches to time-resolved structure determination of membrane proteins. This work will also drastically
reduce sample consumption and will increase the diversity of membrane protein and other biological nano-
objects that can be studied with XFELs. The proposed work also aims to develop new capabilities for time-
resolved structural studies at XFELs to include cross-membrane potential triggered membrane protein
dynamics, enabling investigation of a broader range of biomolecular and cellular reactions and the associated
structural change over a large range of times scales from microseconds to milliseconds. If successful, this work
would greatly aid our experimental capabilities to study and understand function of protein complexes and
biological nanoparticles in a wide range of fields including human health and biosecurity.

Public health relevance
Project Narrative This project will develop new technologies for high-resolution, time-resolved structure determination of membrane proteins by overcoming current challenges in x-ray diffractive imaging of biological samples with x- ray free-electron lasers (XFELs). Membrane proteins perform many critical cellular functions, such as intercellular transport, signaling and enzymatic function, and are medically important—about a third of all human proteins are membrane proteins and account for more than half of all drug targets. Tools for determining the structure and the dynamical behavior of membrane proteins at room temperature with near atomic resolution will greatly improve our knowledge of biomolecular function with direct relevance and impact on biomedicine and public health.